Leveraging Computer Vision to Augment Suicide Risk Prediction

Abstract
Self-injurious behaviors occur at alarmingly high rates among adolescents, with suicide ranking as the second
leading cause of death among those ages 15-24. A history of prior self-injury, including both nonsuicidal self-
injury and suicidal self-injury (e.g., suicide attempts), has been consistently found to be the strongest predictor
of future suicidal behavior, with evidence suggesting that the more severe such behaviors are, the greater the
risk for future self-injury. Importantly, however, our current means of assessing severity of prior self-injury is
almost entirely reliant on self-report, despite the fact that self-injury frequently leaves tangible physical
markings. Although applications of machine learning in medical image analysis are growing exponentially,
none have attempted to augment suicide risk detection through automated analysis of self-directed tissue
damage. Leveraging computer vision to automatically assess images of tissue damage has the potential to
obviate complete reliance on subjective patient report of self-injury severity characteristics. Thus, the objective
of this proposal is to utilize computer vision techniques to automate the assessment of hypothesized self-injury
visual severity indicators, learn new visual severity indicators, and determine the utility of these visual signals
in predicting prospective suicide attempt risk. Community adolescents ages 16 to 18 years old will be recruited
on Facebook and Instagram if they have currently visible physical marking(s) secondary to self-injury.
Participants will securely upload images of markings secondary to intentional self-injury. A subset of
participants will be followed longitudinally for three months to assess prospective suicide attempts. We will
employ deep convolutional neural networks, a class of artificial neural networks, to develop algorithms to
detect severity indices of self-injury and to examine their accuracy in predicting short-term prospective suicide
risk. We will assess the generalizability of a subset of algorithms by applying them to a separate clinical
sample of psychiatrically hospitalized adolescents ages 16 to 18 years old. This proof-of-concept study will set
the stage to determine the feasibility of pursuing our long-term goal of integrating this technology into
psychiatric care entry-points (e.g., emergency departments, inpatient units) to assess whether this technology
can augment current suicide risk assessment models and in turn, serve as a clinical decision-support tool to
help clinicians assess suicide risk. This research is significant in that it aligns with the NIMH/National Action
Alliance for Suicide Prevention’s Prioritized Research Agenda for Suicide Prevention’s Aspirational Goal 2 of
determining suicide risk in diverse populations and settings using feasible and effective assessment
approaches, and Goal 3 of finding novel ways to assess for imminent suicide risk, given that our target
prediction period is three months.

Public health relevance
Project Narrative This application aims to determine whether a computer can analyze pictures of skin damage from adolescents who engage in self-injury and predict who is at risk for making a suicide attempt in the future. Results from this work may help in the development of a clinical decision-support tool to help clinicians assess suicide risk in medical care settings.